Neuroscience Training Program at Washington University

This proposal, from the Neuroscience Program in Washington University’s Division of Biology and Biomedical
Sciences (DBBS), is a new application to the Jointly Sponsored Ruth L. Kirschstein National Research Service
Award Institutional Predoctoral Training Program in the Neurosciences. The overarching goals of our
Neuroscience program are to equip our trainees with a firm foundation in nervous system function and
dysfunction, the ability to identify problems and design strategies to address them critically and rigorously, and
the skills required to perform, present, and mentor others in research. The strengths of our current training
program include a strong and evolving curriculum to address critical areas of modern neuroscience and the
skills necessary for success in any neuroscience career, a focus on improving diversity of students in
neuroscience and retaining diverse students in the program, a collegial and collaborative atmosphere, broad
institutional support, multiple neuroscience-related opportunities for community outreach and teaching and a
supportive administrative structure that facilitates all aspects of the educational process, from recruitment of
students to thesis defense and beyond. This proposal builds on these features with ongoing and future
initiatives aimed at improving quantitative, experimental and statistical thinking, facilitating interdisciplinary
and/or advanced training in areas relevant to a student’s research, modernizing curriculum delivery, providing
evidence-based ethics training to address well-publicized problems of rigor and reproducibility,
and assessing the impact of these initiatives and modifying their implementation as needed. We are requesting
11 slots for students in their 1st and 2nd years. Students will emerge from this program with a stronger
foundation in experimental and statistical thinking, ethics and methods to improve rigor and reproducibility.
Faculty in the program will also benefit from exposure to emerging methods and approaches in these areas.

Public health relevance
This proposal will support innovative training for graduate students in Neuroscience at Washington University in St. Louis. The Program is known for its depth and breadth of molecular, cellular and systems research on the nervous system and its diseases, integrated into strong mentoring, skill and career development opportunities. This new training grant supports the Neuroscience Program’s efforts to develop students’ key skills in statistical, experimental and quantitative reasoning while they address cutting-edge research questions in the brain sciences.